Biphasic mechanisms of injury and repair in stroke therapy

DESCRIPTION (provided by applicant): Biphasic mechanisms of injury and repair in stroke therapy: The role of oxidative stress in stroke is well accepted. However, the recent SAINT-2 clinical trial of a free radical spin trap failed. Here, we propose the hypothesis that oxidative stress plays a biphasic role in stroke. Reactive oxygen species (ROS) are damaging in the acute phase. But they may be involved in neuro- vascular remodeling during stroke recovery. Our pilot data suggest that (i) ROS are required for angiogenesis in brain endothelial cultures; (ii) ROS are required for endothelial production of neuroprotective BDNF; (iii) delayed treatment with ROS scavengers in a rat stroke model suppresses vascular remodeling in peri-infarct cortex; and (iv) delayed ROS scavenging interferes with stroke recovery and ends up exacerbating tissue infarction. To build on these initial data, we will pursue the following specific aims. In AIM 1, we examine the molecular mechanisms that link ROS to angiogenesis. We will use brain endothelial cell cultures to test the hypothesis that SDF-1 triggers an NADPH oxidase (Nox) mechanism that upregulates endogenous ROS. Increased ROS then activates the MAP kinase called JNK, which goes on to upregulate neurovascular mediators such as MMP-9, VEGF and BDNF. The integrated contribution of these signals will be tested in endothelial proliferation, migration, and tube formation assays. Besides resident brain endothelium, circulating endothelial progenitor cells (EPCs) also contribute to neurovascular recovery after stroke. So in AIM 2, we investigate how ROS promotes EPC function. We hypothesize that the same SDF-1, Nox and JNK pathways serve to regulate MMP-9, VEGF and BDNF signals that underlie EPC proliferation, maturation, colony formation and tube formation. Hence, blockade of ROS or Nox is predicted to perturb EPC function. Finally, in AIM 3, we ask whether the cell culture effects studied in the first two aims can be validated in vivo. We hypothesize that early and short-term free radical scavenging will be protective, whereas delayed or prolonged scavenging will end up interfering with remodeling and recovery in rat or mouse stroke models. Similar pro-angiogenic signals will be examined in peri-infarct cortex as well as circulating EPCs. Optical and functional MR imaging will be applied to assess peri-infarct dynamics in vivo. Within the first few hrs after stroke, most events primarily mediate injury. By a few weeks, it is mostly remodeling. But what happens in between? In this project, we ask when damaged brain makes the transition from injury into repair, and how ROS might mediate injury versus benefit during this transition phase. This application is relevant to PA-08-099 Mechanisms of functional recovery after stroke.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is no clinically effective neuroprotective therapy for stroke. Here, we propose that drugs targeting free radicals may need to be carefully considered. This is because while these drugs are beneficial during early stages of stroke, they may inadvertently interfere with the brain's ability to regrow blood vessels and repair itself later on. Our studies will dissect the molecular mechanisms involved, and determine the time course of when this good-to-bad switch occurs. Project Narrative for R01-NS37074 Competing Renewal There is no clinically effective neuroprotective therapy for stroke. Here, we propose that drugs targeting free radicals may need to be carefully considered. This is because while these drugs are beneficial during early stages of stroke, they may inadvertently interfere with the brain's ability to regrow blood vessels and repair itself later on. Our studies will dissect the molecular mechanisms involved, and determine the timecourse of when this good-to-bad switch occurs. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Oxidative stress is probably the most well-studied phenomenon in stroke [12]. So the results from the SAINT-1 trial was exciting. In this large randomized trial, the free radical spin trap NXY-059 appeared to slightly improve modified Rankin scores at 6 months after ischemic strokes [53]. However, this initial excitement turned to dismay when SAINT-2 failed to replicate these initial findings [82]. There may be many potential reasons why SAINT-2 failed [28, 77]. The initial SAINT-1 data was modest at best. NXY-059 may not penetrate the blood- brain barrier (BBB) very well. And some preclinical data did not support a robust protective effect of the drug, when administered more than 2 hrs after ischemic onset. Here, we propose the idea that like many other mediators in stroke, reactive oxygen species (ROS) are not always deleterious. In the SAINT trials, the ROS scavenger was given for 3 days. Why? What is the target, where is it, and how long was it active? Is it possible that delayed or prolonged scavenging of ROS somehow interferes with endogenous substrates of stroke repair and recovery? Our overall hypothesis states that, in contrast to the deleterious actions of oxidative stress during early stages of stroke, homeostatic levels of ROS mediate beneficial angiogenesis and neurovascular remodeling during stroke recovery. Our pilot data suggest that: (i) blocking ROS suppresses angiogenesis in brain endothelial cultures; (ii) blocking ROS interferes with the production of BDNF from cerebral endothelial cells; (iii) delayed treatment with ROS scavengers in a rat stroke model suppresses vascular remodeling in peri-infarct cortex; and (iv) delayed ROS scavenging ends up worsening brain infarction in our rat stroke model. To test our overall hypothesis, we will pursue the following specific aims. Aim 1: Examine the pathways that link ROS to angiogenesis in brain endothelial cells Hypothesis: Stromal-derived factor-1 (SDF-1) induces NADPH oxidase (Nox) signaling which increases ROS. Subsequently, ROS triggers c-jun-N-terminal kinase (JNK) and upregulates the pro-recovery mediators MMP- 9, VEGF and BDNF. Test: Standard proliferation, migration and tube formation assays will be used to measure angiogenesis in brain endothelial cultures. Addition of exogenous SDF-1 will be used to trigger angiogenesis. We will use PBN (a nitrone-based spin trap related to NXY-059) and U83836E (a lazaroid-based scavenger) to ask whether scavenging of ROS can block activation of the JNK-MMP-9-VEGF-BDNF cascades and suppress angiogenesis. The requisite role of Nox will be tested with inhibitors (DPI, apocynin, gp91ds-tat) and endothelial cells from Nox-2 knockout mice. Aim 2: Examine the pathways that link ROS to endothelial progenitor cell (EPC) function Hypothesis: Homeostatic levels of ROS are also required for EPC function. IL-1 amplifies EPC proliferation, maturation, colony formation, and tube formation. This is because IL-1 upregulates SDF-1 and then triggers the same Nox, ROS and JNK pathways that increase MMP-9, VEGF and BDNF. Test: Mouse EPCs will be cultured. Proliferation, maturation, colony formation and tube formation assays will be used to document responses to the IL-1 stimulus. We will use PBN and U83836E to ask whether scavenging ROS will block activation of the JNK-MMP-9-VEGF-BDNF cascades and suppress EPC function. The requisite role of Nox will be tested with inhibitors (DPI, apocynin, gp91ds-tat) and EPC from Nox-2 knockout mice. Aim 3: Test the ROS-promotes-recovery hypothesis using in vivo models of stroke Hypothesis: Neurovascular remodeling after stroke in vivo relies on the same SDF-1, Nox, ROS and JNK pathways that upregulate MMP-9, VEGF and BDNF. So delayed blockade of ROS after stroke interferes with peri-infarct neurovascular remodeling and stroke recovery. Test: First, we use a mouse model of transient focal cerebral ischemia to establish that these molecular pathways of angiogenesis and neurovascular recovery are controlled by ROS. Second, we assess ROS effects in mouse EPCs after stroke in vivo. Third, we will use optical imaging and fMRI to show that delayed treatment with PBN interferes with functional recovery in peri-infarct cortex. Finally, we will map the time-course of this "beneficial to deleterious" transition of ROS scavenging by treating rat strokes at various times ranging from hrs to days after stroke onset.